Administrative Core

CORE A SUMMARY/ABSTRACT
This revised competing renewal Program Project Grant application entitled Discovering and Exploiting
Mechanisms of Neuroblastoma Therapy Resistance is a multi-disciplinary and multi-institutional translational
research Program focused on the unmet need of improving outcomes for children with high-risk neuroblastoma.
We report significant progress towards our original scientific and clinical trial goals and report herein our
ambitious new research strategies as articulated in each Project and Core B. Together, we seek to discover
fundamental mechanisms of de novo and acquired resistance to both standard and newly emerging therapies.
Core A provides the experienced leadership and administrative infrastructure to define priorities, sustain
momentum, and deliver results that meet defined milestones. Thus, Core A will provide the scientific, budgetary,
and administrative leadership, as well as the programmatic infrastructure, to achieve the translational mission of
the proposed investigation across all eight leading childhood cancer research institutions. Unique to our Program
is the New Approaches to Neuroblastoma Therapy (NANT) clinical trials consortium (eleven full member sites,
six guest member sites, and expanding European membership) embedded in Core B, along with biorepository,
pathology, flow cores, and statistical expertise, to enable rapid translation of Project discoveries to our patients.
With the guidance of a world-renowned Scientific Advisory Board, Core A will continue to oversee the
development of a new generation of rationally designed therapies for children with NB that we expect to ultimately
improve cure rates, while simultaneously reducing both short- and long-term toxicities.

Public health relevance
CORE A NARRATIVE Core A is aligned to the public health mission of the National Institutes of Health as it provides the scientific, budgetary, and administrative leadership necessary to continue to achieve the ambitious goal of improving neuroblastoma patient outcomes through this Program. This translational research Program focused on neuroblastoma will continue to provide insights relevant to the broader fields of both pediatric and medical oncology.